Origins, properties, and therapeutic potential of cells that repopulate the microglia-depleted adult brain

Abstract:
Our research focuses on microglia, a type of brain cell crucial to understanding and treating several central
nervous system diseases. In our first funding cycle (2014-2019), we developed a technique to remove and
replace microglia using a drug that targets a specific receptor (CSF1R), which has since become a standard
method in neuroscience. This approach has significantly advanced our understanding of microglia and has
shown therapeutic potential in various disease and injury models. In our second funding cycle (2019-2024), we
further explored microglia replacement and discovered several key findings, including a new method of
reprogramming microglia and a novel route for bone marrow-derived cells to enter the brain allowing us to fully
replace the microglial tissue with bone-marrow derived monocytes/myeloid cells. Building on these findings, we
propose three specific aims for our next research phase. First, we will investigate a new method of microglia
recovery that avoids the need for complete microglia removal. This involves temporarily inhibiting CSF1R,
leading to the reprogramming and proliferation of microglia and other brain cells. Second, we will explore the
potential of replacing dysfunctional microglia with functional bone marrow-derived cells as a treatment for
genetic disorders associated with microglia dysfunction. Lastly, we will study the role of peripheral myeloid
cells entering the brain in the development of Alzheimer's disease. Our research aims to deepen our
understanding of microglia biology and explore its therapeutic potential, moving towards more clinically
relevant applications.

Public health relevance
Project Narrative: Our prior work has resulted in the ability to eliminate all microglia from the brain, via clinically utilized colony- stimulating factor 1 receptor (CSF1R) inhibitors, and to then, following CSF1R inhibitor withdrawal, repopulate the microglia-depleted brain with 1) a new microglial tissue, 2) white matter microglia, or 3) bone marrow-derived monocytes, utilizing a variety of CSF1R inhibitor conditions and paradigms. Here, we will extend our research into more translationally relevant directions to explore how to produce the beneficial effects of microglial repopulation, via transient CSF1R inhibition reprogramming of microglia, without the necessity of excessive microglial death, as well as the utility of microglial replacement with functional bone marrow-derived monocytes for the therapeutic benefit of genetic diseases associated with microglia dysfunction – namely the lysosomal storage disorder Sandoff disease. Finally, we will determine the impact of monocytes on the pathogenesis of Alzheimer's disease using complementary mouse models combined with microglial replacement techniques, with an emphasis on studying the downstream events of monocyte central nervous system infiltration and their plaque-associated interactions.